Community-Engaged Design and Implementation of a Just-In-Time Adaptive Intervention (JITAI) to Improve Adolescent Anxiety in Rural Populations

PROJECT SUMMARY
It is imperative to improve the inclusive reach of effective anxiety treatments for adolescents. Anxiety disorders
are among the most common psychiatric conditions in adolescents (13-17 years old) yet they are largely
undertreated, particularly in rural areas. Behavioral interventions are efficacious in reducing anxiety symptoms
while providing individuals with a toolkit of knowledge, skills, and techniques that empower self-care. As
anxiety disorders involve an interconnected relationship between psychological and physiological processes,
behavioral interventions that combine mind-body practices are coming to be seen as a particularly powerful
therapeutic approach. Such treatments can include physical exercises, expressive movements, and other
activities that emphasize interoception, autonomic reactivity, and the role of the body in processing and
regulating emotions. However, research is needed to tailor these somatic approaches to an adolescent
population, more rigorously evaluate their efficacy in diverse settings, and enhance their accessibility in
traditionally underserved communities. Further, it is key to ensure such interventions are responsive and
available in real-time, considering in-the-moment support is a critical aspect of quality anxiety care. Mobile
technology is a promising platform for delivering personalized behavioral interventions at-scale and on-
demand, including through emerging designs like just-in-time adaptive intervention (JITAI). This project aims to
better understand barriers and enablers to the implementation of efficacious anxiety treatments for rural
adolescents, particularly to inform intervention strategies that leverage increasingly accessible and cost-
effective digital technology to deliver somatic therapies and JITAI support. It will use a community-engaged
research approach that partners with adolescents and other stakeholders, including close collaboration with
local schools to facilitate the tool’s adoption. The intervention will be adapted from an existing mobile health
platform developed by the research team for mobility promotion in adults, which has shown feasibility in
motivating exercise behavior change over time as well as increasing adherence to at-home physical therapy
routines. Specific extensions will involve the integration of somatic therapies, JITAI support, and generally
adjusting the tool’s content and interfaces to the context of reducing anxiety in rural adolescents. Following
qualitative needfinding to understand anxiety experiences and care needs as well as participatory design and
usability testing of the adapted intervention, the tool will be pilot tested with a sample of 50 rural adolescents
experiencing elevated anxiety levels who will be randomly assigned to the JITAI tool or a waitlist control, for a
treatment period of 3 months. Objectives include demonstrating the acceptability, feasibility, and preliminary
efficacy of this intervention approach, while systematically devising a strategy in collaboration with community
partners to facilitate its sustained uptake.